State factors and maternal health among immigrants

PROJECT SUMMARY/ABSTRACT
Health before pregnancy and between pregnancies (preconception) is inextricably linked to health during
pregnancy as well as delivery and infant health outcomes. Insurance coverage increases access to
preconception and postpartum health services yet some immigrants are not eligible for Medicaid before, during
and after pregnancy. Some states use longstanding alternative federal funding mechanisms to provide public
insurance coverage during pregnancy to this group (referred to as “non-qualified (NQ) immigrants”).
Historically, public insurance coverage for non-qualified immigrants outside of pregnancy was extremely rare in
the US. However, states have recently made major strides in expanding public health insurance eligibility for
non-qualified immigrants outside of pregnancy through two new policy pathways. In this project, we will
examine maternal health outcomes among non-qualified immigrants and examine the impact of recent state
policies that expanded public insurance to non-qualified immigrants before and after pregnancy on perinatal
healthcare, and maternal and infant health.
Aim 1: We will use recently modernized national Medicaid claims data 2019-2022 to examine differences in
maternal health outcomes for enrollees covered by Emergency Medicaid compared to full-scope Medicaid
during pregnancy. We will compare rates of severe maternal morbidity and potentially avoidable delivery
complications.
Aim 2. We will examine the impact of California’s 2020 policy to extend public insurance eligibility to all NQ
immigrant adults between ages 19 and 25 on prenatal healthcare and pregnancy outcomes. We will use novel
linked California Medicaid claims and birth certificate data and a difference-in-differences approach comparing
NQ immigrants who were eligible and ineligible for preconception Medicaid on the basis of their age to
estimate the impact of this policy on timely prenatal care use, pregnancy complications, and birth outcomes.
Aim 3. We will examine the impact of New York’s 2023 policy to offer extended pregnancy Medicaid coverage
from 60 days to one year postpartum to NQ immigrants. We will use a novel linked dataset combining New
York Medicaid claims with the universe of state hospital records, as well as clinical records from the state’s
safety net healthcare providers. Using a difference-in-differences approach, we will compare changes in
postpartum healthcare use and health outcomes between NQ immigrants and enrollees covered by full-scope
pregnancy Medicaid to estimate policy impact.
The findings from this project will provide new information on maternal health outcomes among NQ
immigrants, as well as timely and actionable evidence about the impact of extensions of public insurance in the
preconception and postpartum period to NQ immigrants on pregnancy and postpartum health.

Public health relevance
PROJECT NARRATIVE Federal law prohibits states from offering adult or pregnancy-related Medicaid coverage to undocumented and lawfully residing immigrants with fewer than five years of legal residence (also known as “Non-qualified (NQ) immigrants”). Two longstanding federal policies allow states to circumvent these rules to offer non-qualified immigrants public insurance coverage during pregnancy, and more recent state policies provide public insurance coverage to this group before and after pregnancy. In this project, we will examine maternal health outcomes among non-qualified immigrants and examine the impact of recent state policies that have expanded public insurance to non-qualified immigrants before and after pregnancy on perinatal healthcare, and maternal and infant health.